Multi omics mapping of exercise-induced interorgan communication

Project Summary
Exercise offers profound systemic benefits, leveraging multiple molecular pathways and mechanisms to
enhance health. Exercise interventions have been shown to improve symptoms in cancer, cardiovascular
diseases, and neurodegenerative disorders. Molecular mechanisms of exercise in disease prevention and
reversal include anti-inflammatory effects and improved immune function, hormonal regulation, reduction of
oxidative stress, and improved metabolic function. There is a growing body of literature on the individual
pathways activated by exercise in specific disease cases, but a comprehensive investigation across the whole
body is needed to identify pathways and molecules of interest to mediating the systemic benefits of exercise
and complex interorgan communication.
The Molecular Transducers of Physical Activity Consortium (MoTrPAC) has generated an invaluable
resource for identifying molecular changes in response to exercise. We will leverage their exercised rat
profiling (naive, 1, 2, 4, 8 weeks post treadmill). This dataset is unique in being multi-modal and multi-organ
allowing us to capture the broadest repertoire of exerkines and co-profile the expression of their receptors
within the same organ and across organs. We will compare these findings to profiles from healthy (GTEx and
HuBMAP) and diseased (including HTAN and psychENCODE) humans.
We propose to define a comprehensive, multi-organ catalog of exerkines. Using public databases, we
will pair the exerkines with their receptors when known, revealing the whole-body landscape of
exercise-induced signaling. For each organ, we will cross-reference the exerkine and receptor molecules with
the relevant diseased and healthy human dataset to uncover overlapping pathways between disease
dysregulation and exercise modulation. We will bioinformatically simulate single-cell expression data to predict
exerkine and receptor cell types, and further predict cell-cell interactions, validating candidate receptor ligand
interactions by spatial omics assays in the healthy and cancerous human intestine. We will:
Aim 1. Generate and identify exerkines and receptors for 17 organs in MoTrPAC.
Aim 2. Decode exerkines and receptors inter- and intracellular signaling events and synergistic cell-cell
communication
Aim 3. Analyze response of exerkines to disease in humans

Public health relevance
Project Narrative We will leverage MoTrPAC consortium multiomic, multi-organ molecular profiling of the exercised rat to generate a whole body catalog of exerkines, the signaling molecules released in response to exercise. By simulating single-cell data, incorporating previous knowledge networks, and predicting receptor-ligand and cell-cell interactions, we will comprehensively profile exerkine-mediated signaling pathways to uncover complex interactions and map interorgan communication, revealing the molecular mechanisms by which exerkines mediate exercise-induced health benefits. Candidate molecules will be interrogated in healthy (HuBMAP consortium) and cancer (HTAN consortium) datasets.